Roll of Nitrous Oxide (NO) and Cyclic GMP in Cancer

This project focuses on the problem of breast cancer metastasis and recurrence, and on a novel signaling
pathway that is positioned to modulate both. The key signaling molecule is the β1 subunit of soluble guanylate
cyclase (sGC), an enzyme that normally functions as a heterodimer composed of α1 and β1 subunits (termed
here sGCα1 and sGCβ1). In biological models, sGCβ1, but not sGCα1, can translocate into the nucleus, where
it regulates expression of p53 and specific cyclin dependent protein kinases and induces G0/G1 phase arrest.
Moreover sGCβ1, but not sGCα1, markedly inhibits proliferation and colony formation of human cancer cell lines,
and lengthens survival time of orthotropic implanted mice over control. In human breast cancer patients, levels
of sGCβ1 (but not sGCα1) directly correlate with patient survival in authentic breast cancer patients (n =1664).
The hypothesis that altered expression of sGCβ1 in tumor stroma (including epithelial cells, immune cells, and
vascular endothelial cells) alters responses to niche signals and modulates breast cancer recurrence will be
tested by (1) interrogating the effects of sGCβ1 expression on circulating tumor cell (CTC) cluster formation, (2)
examining the role of sGCβ1 expression in modulating breast cancer recurrence arising from angiogenic
dormancy, and (3) determining the ability of sGCβ1-targeted histone deacetylase signaling to reverse immune
dysfunction. Successfully completed, this project will validate the importance of sGCβ1-targeted HDAC signaling
against recurrence of dormant breast cancer, and point the field toward new therapeutic strategies for treating
metastatic breast cancer.

Public health relevance
Metastatic breast cancer affects approximately 155,000 Americans, including military active duty women. The goal of this project is to investigate a new tumor suppression pathway implicated in the control of cancer metastasis and recurrence. Successfully completed, this project will validate the importance of this pathway against recurrence of dormant breast cancer, and point the field toward innovative drug discovery strategies for treating metastatic breast cancer.